IBMPFD MUTATIONS IMPAIR PROTEIN DEGRADATION

DESCRIPTION (provided by applicant): One age associated muscle disorder is due to mutations in valosin containing protein (VCP) which causes IBMPFD/ALS or inclusion body myopathy (IBM) associated with Paget's disease of the bone (PDB), fronto-temporal dementia (FTD) and amyotrophic lateral sclerosis (ALS). Muscle weakness is the most prevalent phenotypic feature. Although IBMPFD itself is rare, the culmination of each component (IBM, PDB, FTD and ALS) makes its incidence more common in the general population. VCP mutations disrupt autophagosome maturation resulting in dysfunctional autophagy and muscle weakness. We propose to develop a methodology to quantitate autophagy in human skeletal muscle.

Public health relevance
PUBLIC HEALTH RELEVANCE: Pathologic protein inclusions accumulate in many divergent disease states associated with aging like inclusion body myositis and dementia. We hypothesis that an impairment in autophagy and autophagy signaling pathways conferred by mutations in the protein VCP result in inclusion body myopathy associated with paget's disease of the bone, fronto-temporal dementia and amyotrophic lateral sclerosis (IBMPFD/ALS). Understanding IBMPFD/ALS and autophagy will lend insight into the treatment of other more common age related disorders.